Zika in Pregnancy Supplemental Funding request

DESCRIPTION (provided by applicant): RTI International (RTI), as the proposed data coordinating center (DCC) for the Eunice Kennedy Shriver National Institute of Child Health and Human Development (NICHD) Global Network (GN), will provide the scientific and operational resources to maximize the scientific productivity and public health impact of the GN research collaborations across diverse research settings in multiple low-income countries. To achieve this aim, RTI will (1) provide scientific and statistical leadership to facilitate feasible, scientificaly sound, and clinically relevant protocols; (2) develop and support innovative, robust, secure, and locally sustainable data management systems (DMSs) that enhance the implementation of the study protocols and increase local research capacity; (3) develop effective data monitoring and safety reports that facilitate study management and oversight; (4) facilitate collaborative, high-quality GN study publications through rigorous analyses and logistical and editorial support; (5) coordinate the acquisition, storage, and tracking of study drugs, equipment, and supplies; and (6) promote efficient study development and implementation through logistical communication support of the GN protocol teams and the External Advisory Board and the Data Safety and Monitoring Board. RTI brings specific strengths that will support the GN's mission to enhance the global research capacity to improve health of women and children in low-income countries: (1) proven scientific collaboration in the leadership of the GN over the past 11 years as demonstrated by the more than 110 collaborative GN manuscripts and the collaboration of E. McClure in extending GN capacity through collaboration with external funding sources; (2) a set of state-of-the art, flexible, established distributed data entry and management tools that will (a ensure high-quality data with rapid error resolution, (b) provide creative solutions to difficult problems like drug distribution in rural areas, and (c) provide site staff with study management and reporting tools that enhance the scientific quality; and (3) statistical expertise in study design that has provided the GN with innovative cluster- and individually randomized designs and quality improvement approaches that address the unique scientific, implementation, cultural, and ethical issues encountered by the GN.

Public health relevance
Public Health Relevance: The Global Network for Women's and Children's Health Research (GN) is a multi-country research network developed to conduct research to identify solutions to reduce important causes of maternal and childhood mortality in developing countries. As the data coordinating center (DCC), RTI will provide the scientific and operational resources to maximize the scientific productivity and public health impact of the GN research collaborations by ensuring sound study design, high-quality data collection and analyses, and efficient communication across these diverse research settings.